DISSECTING THE SPATIAL HETEROGENEITY OF SYNOVIAL INFLAMMATION IN RHEUMATOID ARTHRITIS

PROJECT SUMMARY/ABSTRACT
Analyses of rheumatoid arthritis (RA) synovium have shown that the clinical heterogeneity of the disease is in
part explained by heterogeneity in which cell types predominate in the synovium. However, we lack an
understanding of how these key cell types work together in space, and in particular whether they form
“functional units” of co-localizing cells that interact to create specific immune milieus. Identifying whether these
functional units exist, how they differ across disease subtypes, and how they relate to the immune aggregates
seen in other diseases could improve our mechanistic understanding of synovial inflammation, enable better
disease subtypes, and drive new therapeutic hypotheses. Emerging high-dimensional spatial datasets hold the
key to addressing this challenge, but analyzing them properly poses significant difficulties.
My prior work and preliminary data show that rigorous spatial analysis of inflamed synovium is imminently
possible. Specifically, a statistical tool I developed for multi-sample single-cell datasets turns out to be
extendable to the spatial realm, where it appears powerful and is able to detect spatial correlates of known RA
subtypes even on pilot data. Additionally, I have found that artificial intelligence (AI) can be used to accurately
sort small patches of tissue into groups with similar biological content, enabling comprehensive cataloging of
the types of cellular aggregates in inflamed synovium and comparison to other diseases.
Here, I propose to systematically characterize spatial synovial heterogeneity in RA by applying cutting-edge
computational methods to spatial datasets from RA and other autoimmune diseases. In Aim 1, I will use
advanced statistical techniques to identify the spatial underpinnings of known RA subtypes defined from single-
cell data, and then to define new, spatially informed RA subtypes. In Aim 2, I will use AI to build a map of the
different types of immune- and immune-tissue aggregates in inflamed synovium, and then to identify which are
also present in other autoimmune diseases. These aims will identify the spatial building blocks of synovial
inflammation and relate them to heterogeneity across the spectrum of disease in RA.
This proposal will build important new expertise for me in immunology and spatial methods, and it will enhance
my existing expertise in clinical rheumatology and scientific leadership. I will pursue it in an excellent training
environment with mentors and collaborators who will provide valuable access to key datasets and
methodologic expertise. This training will leave me poised to become an R01-funded investigator who uses AI
and advanced statistics to improve our understanding of rheumatoid arthritis.

Public health relevance
PROJECT NARRATIVE Although the field of rheumatology is beginning to subtype rheumatoid arthritis patients using relative abundances of certain cell types in the synovium, our understanding of what these cell types do and how they work together is limited. In this proposal, we will define how immunity is spatially organized in the rheumatoid arthritis synovium, both across rheumatoid arthritis subtypes and in comparison to other autoimmune diseases, using cutting-edge techniques from statistics and artificial intelligence. This will enable mechanistic understanding of known disease subtypes, discovery of improved disease subtypes, and extrapolation of mechanistic and therapeutic hypotheses from other related diseases.